Origins of plasticity in the establishment of binocular vision

Project Summary
How experience influences the formation of neural circuits during mammalian development remains among the
most fascinating questions confronting developmental neurobiologists. Over the past 50 years, studies of
vision-dependent circuitry forming in the binocular visual cortex in carnivores, non-human primates and the
mouse has led to a deep appreciation of this phenomenon. New technological developments, including the
imaging of neural activity of individual cells in awake behaving animals, single cell labeling and transcriptomics,
and large-scale electrophysiology, has opened the door to revisit classic questions in the field by tracking the
development of individual neurons and cell types. In a series of recent studies, we established that visual
experience soon after eye opening most profoundly shapes the development and refinement of cortical
responses to the ipsilateral eye and that this experience-dependent plasticity sets the upper limit on binocular
acuity. The locus of plasticity in the circuitry of primary visual cortex, and the role played by inhibition, remain
unknown. The goal of this proposal is to systematically interrogate the visual pathway from thalamus to cortex
and within cortex to gain a mechanistic understanding of how visual experience informs the establishment of
cortical responses to the ipsilateral eye and, thus, binocular vision. There are three Specific Aims. In Aim 1, we
will examine the development of the thalamocortical projection to V1 in layer 2/3 and 4 for both eyes. We will
determine whether there are laminar differences in this organization as a function of eye and visual experience.
In Aim 2, we will examine how this geniculate input is integrated by recipient cortical neurons. We will
determine if there are differences in this integration for ipsilateral and contralateral eye inputs to excitatory and
inhibitory neurons and whether visual experience is necessary for its establishment. And in Aim 3, we will
explore and test the role of intracortical inhibition in refining ipsilateral eye input as a function of vision. None of
these measurements have been made for binocular neurons in any species but are critically needed to obtain
an understanding of the origins of high acuity binocular vision. We envision that these studies will establish
general principles by which experience influences the development of the mammalian cortex.

Public health relevance
Project Narrative During early postnatal life our brains are molded by experience, and exposure to adverse environments disrupts normal development often in an irreversible fashion. We use the visual cortex as model for examining how the precise circuitry of the cortex is shaped by experience. Understanding how this process is regulated will provide invaluable insights into how the early brain remains flexible and it will contribute to the development of effective therapeutic approaches to restore flexibility to aging or damaged brains.